Optimizing functional recovery of breast cancer survivors

PROJECT SUMMARY/ABSTRACT
Almost one-third of breast cancer survivors report an inability to fully participate in vocational, social, physical,
and instrumental activities of daily living. Breast cancer survivors who report lower participation in these
activities report lower quality of life and greater depression, and are at risk for shortened survival. The long-
term goal of this research is to address the absence of scalable, accessible, evidence-based interventions that
improve cancer survivors' participation in life roles and activities. The objective of this R01 from a new
investigator is to test a telephone-delivered, Behavioral Activation/Problem-solving (BA/PS) intervention
designed to directly foster activity participation. The BA/PS intervention is a theory-based intervention that was
developed over three pilot studies. Over nine sessions, survivors increase or enhance their participation in life
roles and activities by setting, adjusting, and achieving goals that incrementally adapt their activities and
environments and enhance their personal capacity. This application proposes a randomized controlled trial
(RCT) to evaluate the efficacy of BA/PS for improving activity participation as compared to an attention control
condition within a sample of 300 breast cancer survivors reporting reduced functioning after completing cancer
treatment. In order to maximize diversity, the study will be conducted at two National Cancer Institute-
designated Comprehensive Cancer Centers: Norris Cotton Cancer Center at Dartmouth (NH) and the
University of Alabama at Birmingham Comprehensive Cancer Center (AL). The study will address three
specific aims: (1) To evaluate the effect of BA/PS on participation/productivity in social roles and activities
(primary outcome); (2) To evaluate the effect of BA/PS on quality of life; (3) To evaluate the effect of BA/PS on
the outcomes of coping, goal adjustment, and distress. The trial is designed to test whether the BA/PS
intervention affects the slope of functional recovery over time. The outcome variables listed above are
measured at eight, 20, and 44 weeks after study enrollment, allowing the exploration of both immediate and
sustained intervention effects. The theory-driven, standardized approach is innovative because it directly
promotes resumption of valued activities as identified by each survivor. The telephone delivery method
increases the accessibility of the intervention and has the ability to drive the field forward, in contrast to clinic-
based interventions that only meet the needs of those survivors with the time and ability to return to an
outpatient setting. The proposed research is significant because it helps breast cancer survivors develop
strategies to enhance productivity at home, in the workplace, and in the community, and to create sustainable
lifestyle changes that foster health, participation, and functional well-being. As such, the knowledge gained
from this study has the potential to advance the mission of the Office of Cancer Survivorship (of the National
Cancer Institute) by reducing disability and improving the quality of life of cancer survivors.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it tests a cancer rehabilitation intervention designed to increase breast cancer survivors' return to work, school, and valued life activities. The individualized intervention promotes functional recovery from breast cancer by teaching survivors ways to adapt activities, modify environments, and enhance personal capacity. This proposal reflects the National Cancer Institute Office of Cancer Survivorship's mission to reduce disability and improve the quality of life of cancer survivors.